Evaluation of the effectiveness of Ajjmuurur Baamḷe DSMES in the RMI

ABSTRACT
Health disparities in the Republic of the Marshall Islands (RMI) are striking with extremely high rates of
diabetes and other cardiometabolic diseases. Documented rates of type 2 diabetes mellitus (T2DM) in the RMI
range from 20%-50%. This is significantly higher than global (8.5%) and US (11%) rates. The extreme
disparities in the RMI are exacerbated by a lack of research, lack of funding, a lack of services, and a lack of
culturally-appropriate interventions. Residents of the RMI experience unique barriers to self-management of
T2DM, as well as possess unique cultural assets that can be leveraged to help mitigate these barriers. The
research team worked with the Marshallese community in Arkansas to develop and evaluate a culturally-
adapted family model of DSMES (Ājjmuurur Baamḷe DSMES). Ājjmuurur Baamḷe DSMES is based on a
collectivist approach, incorporates Marshallese cultural practices, and uses “talk story” as a conversational,
rhythmic, and culturally preferred way of sharing knowledge. Ājjmuurur Baamḷe DSMES includes family
members as participants and focuses on family motivational interviewing, family goal setting, and family
behavioral change with specific focus on education about supportive and nonsupportive family behaviors. The
curriculum is assets based and it works to overcome barriers facing Marshallese patients by leveraging
culturally specific facilitators of healthy behavior change. Our central hypothesis is that persons who receive
the Family Model DSMES "Ājjmuurur Baamḷe" will have improved HbA1c (primary outcome), blood pressure,
lipids, BMI, increased knowledge, self-efficacy, empowerment, and quality of life, along with decreased
diabetes-related complications and diabetes-related distress. This study's objective is to conduct a cluster RCT
using a wait-list control to evaluate the effectiveness of Ājjmuurur Baamḷe DSMES when delivered in faith-
based organizations (FBOs) by Community Health Workers (CHWs). Our specific aims are: 1. Test the
effectiveness of Ājjmuurur Baamḷe DSMES to improve diabetes-related outcomes among Marshallese patients;
2. Evaluate the effect of Ājjmuurur Baamḷe DSMES on family members; and 3. Conduct an indigenous
evaluation to understand the extent to which the intervention adheres to Pacific Islander cultural values and
evaluate the cultural appropriateness of the research. Data will be collected from patients (Aim 1) and their
family members (Aim 2) at baseline, immediately post-intervention (12 weeks), at four months and twelve
months post-intervention. An indigenous evaluation (Aim 3) will be conducted at six months and each year
thereafter to document and inform process improvement efforts in study implementation. While the
Marshallese are a small population, this population is underrepresented in research, and they are experiencing
a health crisis that must be addressed. The proposed study offers a promising intervention that has the
potential to affect substantially health disparities experienced by Marshallese and other Pacific Islanders in the
USAPI.

Public health relevance
PUBLIC HEALTH RELEVANCE Marshallese are a subpopulation of Pacific Islanders that are experiencing significant health disparities, with some of the highest documented rates of type 2 diabetes mellitus (T2DM) in the world. Culturally- appropriate diabetes self-management education and support (DSMES) has been shown effective in other minority communities; however, no DSMES has been shown effective and sustainable with Marshallese in the Republic of the Marshall Islands. It is critically important to determine a DSMES intervention that is effective, scalable, and sustainable in this population experiencing extreme health disparities and a crisis in rates of T2DM.